Molecular Determinants of Regional Differences in Human Ventricular Repolarization and Remodeling

ABSTRACT
Heart failure, which afflicts more than five million adults in the United States alone, is associated with markedly
increased risk of ventricular arrhythmias and sudden death. The molecular, cellular and systemic mechanisms
linking heart failure to increased sudden death risk, however, are poorly understood and, despite considerable
attention and effort, risk stratifying patients remains an enormous challenge. Although numerous experimental
(animal/cellular) heart failure models have been developed and extensively studied, only limited insights into
human arrhythmia mechanisms have been provided. Motivated to change this and advance the field, we have
undertaken a comprehensive research effort aimed at defining the mechanisms involved in the physiological
regulation of membrane excitability in the human heart and the pathophysiological electrical remodeling
associated with human heart failure. Utilizing the infrastructure developed in the Translational Cardiovascular
Biobank and Repository at Washington University for the acquisition of non-failing and failing human hearts, we
have established robust, reliable methods for the isolation and in vitro maintenance of human ventricular
myocytes. Here, we utilize these unique resources to test directly the hypothesis that there are regional
differences in the regulation and remodeling of three voltage-dependent conductance pathways critical for the
coordinated propagation of activity through the ventricles and the maintenance of normal cardiac rhythms: the
Kv4.3-encoded, fast transient, outward K+ current, Ito,f; the recently identified, novel, non-inactivating Kv current
component, Iss; and, the Nav1.5-encoded voltage-gated Na+ current, INa. In aim #1, we will define the functional
impact of heterogeneous Ito,f remodeling on LV action potential waveforms, and identify the molecular
determinants of native Ito,f channels in non-failing human LV and of Ito,f remodeling in failing human LV. In aim
#2, we will test the hypothesis that there are also transmural differences in the expression and the remodeling
of Iss, and define the functional consequences of cell type-specific differences in Iss expression and remodeling
on LV action potential waveforms. Experiments in aim #3 will test the hypothesis that there are transmural
differences in the expression, properties and remodeling of Nav1.5-encoded INa channels, particularly the late
component of INa, INa,L, in non-failing and failing human LV myocytes and define the functional impact on LV
action potential waveforms of heterogeneous INa,L expression and remodeling.
These studies will provide new, clinically relevant, insights into the cellular/molecular mechanisms contributing
to the physiological regulation and pathophysiological remodeling of native human ventricular Ito,f, Iss and INa
channels. These insights will transform the refinement of human cardiac myocyte and whole heart models and
translate to novel, mechanism-based strategies to target specific cell types to reduce the risk of life-threatening
ventricular arrhythmias in patients suffering human heart failure.

Public health relevance
Arrhythmogenic cardiovascular disease and sudden cardiac death disproportionately affect individuals with acquired cardiovascular disease, such as heart failure. It is increasingly recognized that the paucity of electrophysiological data on the human heart has been a persistent barrier to advances in heart failure diagnosis and treatment. Here, we propose a unique experimental strategy to identify the electrophysiological signature(s) of remodeling in human heart failure-related arrhythmogenic cardiovascular disease, information that will reveal new targets to treat heart failure and new strategies to prevent sudden death.